Cardiac microtubules as regulators of diastolic function.

Abstract
Diastolic heart disease (DHD) is the leading cause of death and disability worldwide. With no FDA approved
therapies to improve diastolic function, the NIH has placed special emphasis on collaborative initiatives bridging
basic science and clinical data to understanding the molecular mechanism of DHD. The hallmarks of diastolic
heart disease are a stiffening left ventricle and an inability for the heart muscle to relax, both of which occur in
DHD by mechanisms that are poorly understood. Building on recent work that the cardiac microtubule network
(MTN) can both stiffens and impairs the relaxation of failing cardiomyocytes, in Aim 1 we determine the relative
contribution of the MTN to myocardial stiffness in intact preparations of HTN and DHD ventricular myocardium.
We isolate the myocyte and fibrotic contribution to stiffening and use complimentary reductionist approaches to
isolate the relative contributions of actomyosin activity, passive titin stiffness, and the MTN to myocyte
mechanics. In Aim 2 we extend these findings into a clinically analogous ex-vivo working myocardial slice
preparation to dissect the MTN impediment to the phases of diastole in HTN and DHD. The working preparation
allows us to contextualize the findings in Aim 1 with the emergent properties arising from cyclically contracting
loaded myocardium. Thus, by carefully designing a series of complementary assays we will resolve the
molecular contributions to cardiac stiffening and impaired relaxation in DHD, and in doing so determine the
potential for MTN-targeting therapies in DHD.

Public health relevance
NARRATIVE Diastolic heart disease (DHD) is the leading cause of death and disability worldwide. Diastolic dysfunction is caused by stiffening of the heart and impaired relaxation which occur by unknown molecular mechanisms. In this proposal, the PI and colleagues determine if cardiac microtubules underlie diastolic dysfunction in DHD. In Aim 1 they demonstrate that hypertension and metabolic syndrome are cooperative stabilizers of the cardiac microtubule network and determine if cardiac microtubules are molecular regulators of myocyte and myocardial stiffness. In Aim 2 the PI and colleagues leverage newly developed working myocardial preparation to quantify the cardiac microtubules influence on diastolic performance in normal, hypertensive and DHD myocardium. Together, the results determine the contribution of cardiac microtubules to diastolic dysfunction and demonstrate the potential for microtubule target drugs as a new class of therapies for DHD.